Risk Factors for Clinically Aggressive Melanoma in Veterans

Malignant melanoma is one of the top five cancers in Veterans. If diagnosed early, like the
majority of melanomas in the U.S., it is highly curable with local surgery alone in the outpatient
setting. In contrast, clinically aggressive melanoma, defined in this proposal as tumor stage
pT1b, requires sentinel lymph node biopsy under general anesthesia and has a worse
prognosis, accounting for a double the number of melanoma deaths compared to early-stage
disease. There are no melanoma screening guidelines, and thus, there is a critical need for
personalized easy-to-use approaches for melanoma screening to improve health outcomes and
reduce treatment costs. Dr. Rebecca Hartman is a clinical dermatologist and researcher in
epidemiology and health services research who seeks to improve melanoma screening
approaches through personalization of risk assessment in a clinically applicable manner. The
aims of this CDA-2 proposal are to (1) create and validate a clinical risk prediction model for
clinically aggressive melanoma in Veterans and (2) create a genetic risk prediction model for
clinically aggressive melanoma in Veterans and validate a combined genetic and clinical risk
prediction model in an external civilian cohort. Aim 1 will conduct logistic regression analyses to
examine for associations between potential phenotypic risk factors and clinically aggressive
melanoma, including demographics, co-morbidities, disease history, immunosuppression,
military history, environmental exposures, and healthcare utilization. This aim will produce an
easy-to-use clinical risk prediction model for clinically aggressive melanoma that is specific to
Veterans and can be integrated into the electronic health record. Aim 2 will conduct a candidate
gene analysis of previously established cutaneous melanoma SNP risk factors as well as
GWAS to examine for novel genetic risk factors for clinically aggressive melanoma. Cox
proportional hazards regression will be used to create a polygenic risk score for clinically
aggressive melanoma and model performance will be evaluated using decile percentiles of risk
and ROC curve. This aim will produce a polygenic risk score for clinically aggressive melanoma.
Subsequently, the combined clinical and genetic risk prediction model will be validated in an
independent civilian cohort using the Mass General Brigham Biobank. Future directions include
a clinical trial of the clinical risk prediction model, integrated into the electronic health record, to
examine prospective real-world model performance as well as examination of any novel genetic
associations found in GWAS for potential therapeutic applications. This clinical risk prediction
tool will help VA clinicians select patients to triage to dermatology for melanoma screening. The
mentorship, research, and training programs described in this CDA-2 application will propel Dr.
Hartman’s career as an independent VA-based dermato-epidemiologic researcher. Her
mentorship team includes Drs. Mary Brophy, Maryam Asgari, Michael Gaziano, Nathanael
Fillmore, and Luc Djousse, who are experts in oncology, dermato-epidemiology, epidemiology,
genetic epidemiology, and big data analysis from the Massachusetts Veterans Epidemiology
Research and Information Center (MAVERIC) and the Harvard Dermatology Program. Through
this CDA-2 application, Dr. Hartman will develop skills in big data analysis, risk prediction
modeling, and genetic epidemiology as well as undergoing professional development to prepare
her to apply for a VA Merit Award and continue toward becoming an independent VA-based
clinician researcher.

Public health relevance
This research proposal seeks to create screening approaches for aggressive melanoma specific to Veterans, who as a population, are more likely to develop melanoma than civilians. We will use data from the national VA healthcare system and the Million Veteran Program to create a tool that can identify those at greatest risk of developing aggressive melanoma using clinical and genetic risk factors. This tool can subsequently be used by clinicians to identify Veteran patients who will benefit most from melanoma screening. This proposal directly aligns with two of the four stated VA strategic research priorities, including to “increase the substantial real- world impact of VA research” as the risk prediction model can be trialed as a clinical decision support tool and to “put VA data to work for Veterans” by using the rich VA dataset to obtain information that will benefit both Veterans and the nation.